Structures and Toxicity of Amyloid Protein Assemblies in Alzheimer's

DESCRIPTION (provided by applicant): The long-term objective of this research is to identify the origin of neural cell deaths observed in Alzheimer's disease (AD) through investigating molecular details of three types of highly toxic protein assemblies of Alzheimer's β-amyloid (Aβ), which are commonly observed in AD. The formation of senile plaques in a brain is a hall mark of Alzheimer's disease (AD); the primary component of the plaque is fibrillar assemblies comprised of Aβ. Because Aβ exhibits toxicity through self-assembly into larger aggregated forms (i.e. monomeric Aβ is non-toxic), it has been long suspected that misfolding of Aβ resulting in the fibril formation and structural changes of Aβ via the self-assembly trigger the onset of the toxicity and the neural dysfunctions in AD. Indeed, the toxicity of the aggregated Aβ is greatly modulated by morphologies of the assembled Aβ, subtle difference in the sequence, and the presence of particular ligands such as Cu(II). In this research, we will examine atomic-level structures of three distinctive forms of toxic amyloid aggregates for Aβ by solid-state NMR (SSNMR), which has been used as a primary tool in structural analysis for amyloid fibrils, including those for Aβ. In Aim 1, we will examine a popular hypothesis that the toxicity of Aβ is associated with Cu(II) binding to Aβ aggregates. It is widely believed that Cu(II)-bound amyloid aggregates may catalyze reactions producing H2O2, which is toxic to neural cells. However, because of the intrinsic heterogeneity of the fibrils, traditional methods in structural biology such as X-ray crystallography and solution NMR are not effective for analysis of the metal-binding structures. With SSNMR, we will examine the location and the mode of Cu(II) binding to Aβ as well as any structural changes due to binding. In Aim 2, we target the structure of amyloid fibrils and diffusible subfibrillar aggregates for Aβ(1-42), which have been poorly characterized, despite their pathogenic importance, because of the extreme difficulties in sample preparation. Molecular structures of these amyloid fibrils and intermediates for Aβ(1-42) have attracted broad attention since the structures offer insights into designs of new therapies and early detection for AD. We will overcome the sample preparation problems by using a novel sensitivity enhancement method, which minimizes sample amount required for SSNMR. The studies will reveal the first site-specific structural details of highly neurotoxic amyloid fibril and intermediate for Aβ(1-42) by SSNMR. In Aim 3, we characterize structure and kinetics in misfolding for E22G Aβ(1-40), which is a unique pathogenic mutant that promotes formation of subfibrillar aggregates. Our study aims to reveal site-specific conformations for E22G Aβ(1-40) fibrils and subfibrillar aggregates for the first time. The neural toxicity of the relevant amyloid aggregates will be examined on mouse PC12 cells.

Public health relevance
This project provides detailed molecular structure for neurotoxic proteins, which are likely to play central roles in development of Alzheimer's disease. The research will provide insights into rational designs of drugs for Alzheimer's.